SCH: A Novel Bias-mitigated Multimodal Oxygen Monitor

Annually, ∼300,000 neonates are admitted to the neonatal intensive care unit (NICU) in the U.S., mostly
due to respiratory distress. After a successful medical treatment in the NICU, earlier discharge to a stable
home life could improve the chance of survival for neonates. However, the outpatient management of
babies with fragile respiratory status is challenging in the absence of reliable remote monitoring devices
suitable for use at home. Due to the small form factor and ease of use, contemporary home monitoring
devices deploy sensors measuring SpO2, the saturation of hemoglobin bound to oxygen. Nevertheless,
accurate assessment of oxygenation is complicated and not possible with only one parameter. Therefore,
in clinical practice, invasive blood gas measurements - including partial pressure of oxygen (PaO2), which
is the free dissolved oxygen (not bound to hemoglobin) - are not entirely replaced with SpO2. PaO2 is an
essential cardio-respiratory measurement and the direct indication of lung effectiveness. A direct
noninvasive method of assessing PaO2 is PtcO2, oxygen gas that diffuses through the skin. Creating an
ability to sense two respiratory parameters (PtcO2 and SpO2) with one wearable is unique and superior to
the current practice of measuring only SpO2, filling an important gap in miniaturization of the
transcutaneous blood gas monitors.

Public health relevance
Inaccuracies in SpO2 measurement have come under scientific scrutiny during and after the pandemic. An active public engagement discusses the consequences on people of color. The known design flaw of SpO2 measurements must be corrected to improve accuracy and reliability. Relying on the fact that PaO2 is the primary determinant of SaO2 in the blood and our multimodal sensor can measure the direct surrogates of these parameters, this opportunity allows us to exploit concurrent measurements of these parameters to develop a unique approach that reduces measurement discrepancies oxygenation assessment.